One cell, one cancer: a novel genetic approach to mouse models of human cancer initiation

The majority of human cancers arise from single cells, which reside within scattered, sporadic
clones of mutant cells that harbor latent oncogenic potential. In the case of pancreatic ductal
adenocarcinoma (PDAC), one of the deadliest human cancers, that oncogenic potential is
conferred by driver mutations in genes including KRAS, TP53 and CDKN2A. As with many human
cancers, genetically engineered mice have been generated to model the initiation and progression
of PDAC, based on inducible mutations in these same genes. While highly reproducible and
capable of mimicking many fundamental aspects of human PDAC, these models fall short with
respect to the one cell-one cancer paradigm, as they develop multiple unique primary cancers
that metastasize independently and cooperatively. This reflects the use of genetic models,
primarily using the Cre-loxP system, in which oncogenic mutations are induced across the entire
organ. This also creates a pro-inflammatory milieu that is not seen in human patients. Attempts
to induce more discrete and sporadic mutations, using dose-dependent inducible Cre models,
face inherent hurdles based on the biology of recombination, and cannot reliably induce cells with
multiple genetic lesions in an otherwise wild-type tissue, as is seen in humans. These problems
apply across mouse cancer models, and we propose to solve them for PDAC, using a novel dual-
recombinase system termed “FLP-out.” This approach is designed for inducible, dose-dependent
irreversible activation of Cre within single cells, which will then delete all copies of any floxed
alleles in their genome, as well as become irreversibly marked by fluorescent protein expression.
In Aim 1 of this limited, technology-oriented project, we will create the FLP-out mouse using a
novel CRISPR-Cas9-based knock-in approach, and in Aim 2 we will validate its function for
modeling PDAC initiation. This model will be of considerable use to the PDAC community, and
we hope that our methodology will be adopted by researchers modeling other human cancers.

Public health relevance
Human cancers begin with a single isolated cell, which accumulates tumor-causing mutations that drive it to grow, invade and migrate, ultimately threatening the life of the host. The mutational process that underlies pancreatic cancer is relatively well understood, and many aspects of it can be reproduced in genetically engineered mice. These mice can then serve as test subjects for new therapies and early detection methods, as well as to understand the basic biology of pancreatic cancer. However, existing mouse models do not follow the human pattern of arising from a single mutant cell; instead, due to inherent limitations in mouse genome engineering, they develop multifocal cancers that are not seen in humans, and also exhibit abnormal inflammatory responses. Here, we propose to develop a new approach to mouse cancer modeling, applicable to the pancreas but also other tissues, which for the first time will allow investigators to mimic the process of mutation accumulation and cancer initiation from single, isolated cells.